Premature aging disorders, metabolites, and atherosclerosis

Project Summary/Abstract
Premature senescence-triggered vascular diseases (PmSVD) induced by ionizing radiation (IR), as well
as Hutchinson-Gilford progeria syndrome (HGPS), are notably characterized by accelerating processes
of atherosclerosis (AthS) and coronary artery disease (CAD). Although endothelial dysfunction in PmSVDs is well
known, there is a paucity of available treatments to prevent PmSVD-induced CAD; hence, there is an urgent need to
fill this gap. Persistent senescence-associated secretory phenotype (PISP), provoked by TL dysfunction, plays a
central role in cancer recurrence and resistance, but its regulatory mechanisms and contribution to AthS remain
unknown. Our long-term goal is to determine the molecular mechanisms by which PmSVD induces PISP in
endothelial cells (ECs) and CAD. PmSVD significantly up-regulated TOP2β degradation via PKCζ activation. The
depletion of EC TOP2β instigated PARP activation and PISP; it also accelerated AthS. We showed the critical
role of mtROS in PKCζ activation, which is one of the initial steps for the Mt-nucleus feedback loop. Of note, the
crucial role of mtROS in both IR and HGPS has been well established. Lastly, by performing IC-MS analysis in both
IR and HGPS ECs, we also found that the following 3 metabolite-related pathways were regulated in IR and HGPS
ECs in common: 1) nucleotide sugars-glycosaminoglycans (GAGs) and sulfate, 2) glutamate, and 3) NAD+-
hydrogen sulfide (H2S). Although the contribution of all 3 metabolites pathways to CAD and aging has been
suggested, the exact role and mechanical insights in regulating PmSVD remain largely unknown. We propose the
novel hypothesis that PmSVD-induced mtROS activates the PKCζ-TOP2β module, followed by TOP2β
degradation, and instigates TL DNA damage. TL DNA damage promotes PARP activation, which induces mt
dysfunction and forms an mt-nucleus feedback loop, resulting in persistent metabolites changes, including
nucleotide sugars and NAD+-H2S pathways, causing PISP and CAD. We will test our hypothesis by pursuing the
following 3 specific aims: In Aim 1, we will determine the role and regulatory mechanisms of the following 3 common
metabolites-related pathways in PmSVD in vitro; 1) nucleotide sugars-GAGs and sulfate, 2) glutamate, 3) NAD+-
H2S. in Aim 2, we will characterize the role of PKCζ-TOP2β module and PARP1 in PmSVD-mediated metabolites
changes and mt dysfunction in vitro. In Aim 3, we will determine the role of the PKCζ-TOP2β module and
subsequent PARP activation in PmSVD-induced coronary AthS (CAthS) in vivo. The proposed work is
expected to establish the roles of PKCζ-TOP2β and PARP as the hub molecules in regulating PmSVD-induced
metabolite changes and PISP. The approach is innovative because we will use the new technologies of iPSC, ion
chromatography-mass spectrometry (IC-MS), machine learning, imaging mass cytometry, and a novel mouse
CAthS model. The proposed research should positively impact PmSVD by leading to a novel approach to
inhibiting PISP.

Public health relevance
PROJECT NARRATIVE The mechanism by which the incidence of cardiovascular events is increased in premature senescence- triggered vascular diseases (PmSVD) induced by ionizing radiation (IR) and in patients with Hutchinson- Gilford progeria syndrome (HGPS) remains largely unknown; hence, there is an urgent need to correct this gap. PmSVD promotes the pro-inflammatory senescent phenotype in endothelial cells, leading to increased cardiovascular disease, but the molecular mechanisms remain largely unknown. Our proposed studies will provide insights into how PmSVD promotes cardiovascular dysfunction and facilitates the development of new therapeutic approaches for PmSVD-induced atherosclerosis.